Diet Interventions, by Race, Evaluated as Complementary Treatments for Pain (DIRECTPain)

Diet Interventions, by Race, Evaluated as Complementary Treatments for Pain (DIRECTPain)
Project Summary
Knee osteoarthritis (OA) is the most prevalent form of arthritis and a significant cause of disability in the U.S. and
race is a risk factor for poor outcomes. Non-Hispanic Black individuals (NHB) report greater OA-related disability
and pain severity compared to their Non-Hispanic White (NHW) counterparts. These disparities are reinforced
through social and biological mechanisms, ultimately resulting in dramatic racial disparities in pain experience
and associated quality of life. Current national efforts to reduce analgesic utilization highlight the critical need for
safe and effective alternatives for pain relief for underserved/at-risk populations. Low-carbohydrate diets (LCDs)
reduce inflammation and pain independent of weight loss, indicating that diet interventions offer a non-
pharmacological complementary treatment. However, racial differences exist in metabolism that are rarely
addressed in diet interventions. NHBs tend to have low insulin sensitivity and are at greater risk for developing
metabolic disorders, suggesting altered carbohydrate responses. Therefore, a LCD may have greater pain-
reducing effects in NHBs and provide a complementary (or alternative) treatment for pain. Here, we will recruit
male and female NHB (n=100) and NHW (n=100) adults with knee OA to complete our two-phase protocol.
Phase 1 will involve a 3-week diet run-up that will allow for quantification of pain measures, psychosocial
variables (socioeconomic status, nutritional knowledge, proximity to grocery stores, food insecurity), and diet
quality to provide a baseline for comparison. Phase 2 will be a 6-week diet intervention (LCD or USDA diet) in
which both groups will be provided with all meals at the direction of study personnel and input from participants.
Evoked pain, measures of pain disability, severity, catastrophizing, and interference will be assessed every 3
weeks in addition to QOL measures, mood, and depression. Physiological variables will be assessed through
blood draws (inflammatory profile) and dual-energy X-ray absorptiometry scans (DXA; body composition,
visceral fat) at the end of Phases 1 and 2. This will be the first study to examine the efficacy of these diets to
reduce knee OA pain with an emphasis on race and interactions with biopsychosocial variables. Changes in all
pain measures following Phase 2 will be assessed with respect to published measures of clinically-meaningful
differences in pain and disability, as well as for statistical significance. The central hypothesis is that the LCD will
improve pain and QOL in participants with knee OA with a greater effect in NHBs than NHWs.

Public health relevance
Diet Interventions, by Race, Evaluated as Complementary Treatments for Pain (DIRECTPain) Project Narrative Racial disparities in knee osteoarthritis (OA) pain may be reduced through adoption of a demonstrated pain- reducing, low-carbohydrate diet (LCD). The overall aim of this study is to examine the efficacy of the LCD to reduce evoked pain and to determine the contribution of race to these effects, with an emphasis on psychosocial variables. We believe that the reduction in evoked and self-reported knee OA pain will be modulated by race, wherein Non-Hispanic Black individuals will experience greater benefit from the LCD, providing an alternative to opioids for pain relief and reducing racial disparities in knee OA.